MULTIDIMENSIONAL MODELING--A NEUROIMAGING RESOURCE

Our proposed neuroimaging Resource for multi-dimensional modeling will go beyond current atlases and maps of brain that assume a static morphology and prohibit the examination of time varying changes. We will develop the framework and tools to rigorously evaluate dynamic changes in brain structure and function focusing particularly on processes such as development, aging and the progression of specific diseases. We have identified four areas of research that are of critical importance: Surface Parameterization, Volume Parameterization, Anatomical Fundamentals and Visualization of Animation. Each of these complements the other to form an integrated and comprehensive research program. The unique focus on multi- dimensional modeling is in contrast to many other neuroimaging centers where the focus is on image acquisition. Our plans include collaborations with a diverse and well funded group of basic, applied and clinical scientists working on neuroscientific problems and health and disease. These projects were selected on the basis of their mutually beneficial, symbiotic relationship with our core research plans and the specific aims of their funded projects. Plans are provided for service to other investigators in the form of robust software access to computer hardware resources and distribution of unique data sets. We will disseminate information about our Resource by publication, electronic media and the creation of video animations of our results. Training opportunities for students and colleagues will be available on site or remotely and will include hands-on experiences, prepared material, workshops, and interactive electronic presentations. 7 An administrative structure and national recognized advisory board will be created to manage the responsibilities of the Resource. Our plans for this Resource build upon an extensive history of research in image analysis, morphometric variability, brain mapping and visualization. This, coupled with our NCRR pre-resource experience, position us perfectly to created and direct an outstanding Resource.